Effectiveness of the HPV Vaccine in Immunocompromised Populations

PROJECT SUMMARY/ABSTRACT
Immunocompromised individuals—such as people with HIV (PWH), autoimmune conditions, and a history of
solid organ or hematopoietic stem cell transplantation—bear a significantly higher burden of human
papillomavirus (HPV)-related anogenital disease compared with immunocompetent people. While HPV
vaccination offers a key opportunity for prevention, studies in immunocompromised populations have primarily
evaluated vaccine immunogenicity and safety. Many of these prior studies demonstrated reduced antibody
seroconversion rates and duration of immune responses for immunocompromised populations compared with
the general population. While this may translate to attenuated protection against anogenital disease, additional
studies that directly evaluate vaccine effectiveness (VE) are warranted to inform optimal use of HPV vaccine in
these high-risk individuals. To date, there have only been a few HPV vaccine trials in PWH evaluating clinical
disease (e.g., condyloma, cervical dysplasia/cancer, and anal dysplasia/cancer), but these were limited by
sample size, and none were conducted in people with non-HIV immunocompromising conditions. To address
these major knowledge gaps, we propose a cohort study in two integrated health systems to evaluate HPV VE
for preventing anogenital disease among three distinct groups of immunocompromised people: (Aim 1) PWH;
(Aim 2) people with autoimmune conditions (i.e., systemic lupus erythematosus [SLE], rheumatoid arthritis
[RA], and inflammatory bowel disease [IBD], each evaluated separately); and (Aim 3) people with a solid organ
or hematopoietic stem cell transplant history. We will evaluate VE for incident disease and recurrent disease
among those treated for prior anogenital lesions. We will also perform HPV genotyping on archived anogenital
clinical specimens to estimate VE for cervical and anal dysplasia/cancer associated with vaccine-targeted HPV
types. Finally, we will evaluate VE by key vaccination characteristics, including age at vaccination, doses, time
since vaccine, vaccine timing (before/after immunocompromising condition), and disease-specific factors (e.g.,
CD4 count for Aim 1, immunosuppressive medication use for Aim 2, and transplant type for Aim 3). We
anticipate cohorts of ~35,000 PWH, ~15,800 with SLE, ~25,100 with RA, ~34,300 with IBD, and ~21,300 with a
transplantation history from years 2006-2022. We will also assemble cohorts of 20:1 demographically matched
immunocompetent people to enable comparison of VE estimates with the corresponding immunocompromised
groups. We are uniquely positioned to address the Aims given the large samples, long-term membership
retention, detailed electronic health records, and archived tissue specimens. We anticipate our findings will
inform tailored HPV vaccination strategies for diverse immunocompromised populations, including clarifying
potential boosting options and benefits of extending catch-up ages, and will therefore be of great interest to
guideline groups, clinicians, and patients.

Public health relevance
PROJECT NARRATIVE Immunocompromised people bear a much higher burden of human papillomavirus (HPV)-related anogenital disease compared with immunocompetent people; unfortunately, for immunocompromised people, studies evaluating the effectiveness of the HPV vaccine have been limited. In this study, we will evaluate HPV vaccine effectiveness to prevent anogenital condylomas, cervical and anal dysplasia/cancer in people with HIV, autoimmune conditions, and an organ or hematopoietic stem cell transplantation history. Findings will help optimize HPV vaccination strategies for immunocompromised people, including clarifying catch-up ages and potential boosting strategies.